IGF::OT::IGF Task Order 74: 2017 Behavioral and Social Sciences (BSS) Early Career/Junior Investigator Meeting: A Workshop on Professional Development in Cancer Prevention and Control Research

2017 Behavioral and Social Sciences (BSS) Early Career/Junior Investigator Meeting: A Workshop on Professional Development in Cancer Prevention and Control Research